Cardiac 1H MRS assessment of NAD+ after Tetralogy of Fallot repair

PROJECT SUMMARY
Tetralogy of Fallot (TOF) is a common form of congenital heart defect that occurs in 1 in 3,000 live births. Surgical
correction often results in pulmonary valve insufficiency (PI), or pulmonary regurgitation, which negatively
impacts the right heart, increasing preload and causing right ventricular (RV) dilatation. Because arrythmia and
sudden cardiac death are potential severe adverse outcomes, PI is often an indication for valve replacement.
The timing of valve replacement is controversial and there is an increasing focus on determining optimal timing
prior to the onset of overt symptoms. This requires a better understanding of the pathophysiology of the chronic
RV volume overload condition that results from TOF repair. Ventricular volume overload is associated with
pathologic metabolism and increased oxidative stress. In particular, nicotinamide adenine dinucleotide (NAD+)
has a central role in the response to oxidative stress. However, the relationship between NAD+ and oxidative
stress in RV volume overload is poorly understood in part due to limitations of in vivo methods. Current methods
to measure NAD+ include high performance liquid chromatography and 31P magnetic resonance spectroscopy
(MRS), but these methods are limited by their invasiveness and low sensitivity, respectively, and are difficult to
translate into clinical use. 1H downfield MRS is an emerging MRS technique that measures the resonances of
elusive signals in downfield (>4.7 ppm) part of the MR spectrum. Downfield MRS has remained underexplored,
yet emerging spectrally-selective RF excitation for the downfield spectrum has shown the possibility to measure
NAD+ in vivo using 1H MRS. I hypothesize that downfield 1H MRS techniques will be able to measure myocardial
NAD+ noninvasively for the investigation of the relationship between NAD+ and myocardial oxidative stress in
RV volume overload post-TOF repair. I plan to use downfield MRS to measure myocardial NAD+ ex vivo in the
RV in an ovine model of TOF repair. I will then associate NAD+ measured with downfield MRS with NAD+ and
markers of oxidative stress measured using invasive molecular techniques. I will further develop a pulse
sequence to measure NAD+ in vivo using downfield MRS in the myocardial septum and validate it with explant
measurement of NAD+. I anticipate the results of this investigation will advance scientific knowledge regarding
the pathologic metabolism of RV volume overload. This study will also result in the development of new methods
to measure NAD+ in other myocardial diseases. This training experience will provide opportunities to build my
expertise in cardiovascular physiology, congenital heart disease pathophysiology, medical imaging physics, and
data analysis. I will be publishing articles on my downfield MRS findings and communicating the impact of this
work in medicine at various internal and external symposia. This research will be conducted under the mentorship
of experts at the University of Pennsylvania in cardiovascular MRI (Walter Witschey), pediatric MR and
congenital heart disease (Mark Fogel) and animal models of heart disease (Robert Gorman).

Public health relevance
PROJECT NARRATIVE Tetralogy of Fallot (TOF) is a common congenital heart disease that affects 1 in 3000 children, and while TOF surgical repair is part of standard care in the first year of life, some patients have poor valve function and heart disease. There is a need for additional information about which patients will develop heart disease to guide the timing of surgery and improve our scientific understanding of this condition. The purpose of this proposal is to develop magnetic resonance (MR) techniques to understand myocardial metabolism following TOF repair.